Immune-induction of lipid droplets in Drosophila larval hemocytes

Lipid droplets (LDs) are cytoplasmic fat storage organelles with fundamental roles in lipid
metabolism, energy homeostasis, and signal transduction. In many infectious diseases, they
accumulate in immune cells and can positively or negatively affect the ability of the organism to
respond to infection. Despite important advances, it is difficult to assess the relevance of
immune-induced LDs for the organism as a whole. Drosophila models have a great track record
for providing generally important insights into both innate immunity and LD biology. The
proposed project takes advantage of Drosophila to study the intersection between these fields.
When Drosophila larvae are infected with bacteria, their macrophage-like blood cells
(hemocytes) rapidly accumulate LDs. This response can also be triggered by bacterial cell wall
components and depends critically on proteins of the Imd pathway, in particular the NF-kB
transcription factor Relish. It is a very rapid response, with LD accumulation detectable within 40
minutes of stimulation. The deep conservation of other aspects of innate immunity and LD
biology between flies and mammals suggests that this response could be broadly important.
However, because a mechanistic understanding is lacking, it is currently impossible to test the
biological significance of the response. This project will employ a two-pronged approach to
uncover the underlying mechanisms of immune-induced LD formation. We will determine in
which tissues/cells NF-kB/Relish functions to drive LD formation, with a tissue-specific RNAi
approach. The role of other components of the Imd pathway will also be tested as well as
whether the response relies on the known function of Relish as a transcriptional activator. To
determine how the hemocyte LDs form, various pathways involved in LD biogenesis and
turnover will be manipulated experimentally and the consequences for LD accumulation
examined, both in the basal state and after immune induction. These studies will generate the
tools and intellectual framework to test mechanistic hypotheses about the functional role of
immune-induced hemocyte LDs and will illuminate macrophage lipid metabolism in general.

Public health relevance
Lipid droplets are cellular organelles that store fat. They are increasingly recognized as important for how organisms fight pathogens. Using a fly model, this project will determine how white blood cells accumulate lipid droplets in response to infection, laying the groundwork for determining the function of this process.